ER and post-ER quality control of integral membrane proteins

Approximately one-quarter of all proteins synthesized in human cells integrate into the membrane of the
endoplasmic reticulum (ER) as they are translated. However, membrane protein folding is problematic. First,
structurally diverse integral membrane proteins face the challenge of folding co-translationally and post-
translationally in three chemically distinct environments: the ER lumen, the ER membrane, and the cytoplasm.
Second, many of these transmembrane domain (TMD)-containing proteins transport ions and other hydrophilic
solutes, so sequences within TMDs favor amino acids containing charged and polar side chains. While these
amino acids facilitate substrate transport, they are also inherently unstable in the membrane. And third, most
ion channels and transporters are oligomeric, so each subunit must find its partner(s) after membrane
insertion. As a result of these hurdles, membrane proteins fold inefficiently, and inherited mutations can further
compromise folding efficiency. To overcome toxic effects arising from misfolded protein accumulation, the ER
is equipped with a pathway to remove nonnative and incompletely assembled species. This disposal pathway,
first reconstituted and named by the PI, is known as ER associated degradation (ERAD). To date, nearly 70
substrates, most of which are membrane proteins, are linked to various diseases and arise from the targeted
destruction of misfolded proteins in the ER. Since its discovery, the PI’s long term research objectives have
been to dissect individual steps during ERAD. This pursuit has focused on the molecular mechanisms
underlying substrate selection, retrotranslocation from the ER into the cytosol, ubiquitination, and degradation
by the 26S proteasome. In parallel, the Brodsky lab has helped define the molecular etiology of nearly a dozen
diseases. Yet, critical unanswered questions in the ERAD field remain, including: (1) How does the ERAD
pathway handle aggregation-prone membrane proteins, which might be difficult to retrotranslocate from the ER
membrane? (2) Are other pathways required to eliminate these toxic aggregated species? (3) What is the
mechanism that prevents misfolded integral membrane ERAD substrates from trafficking beyond the ER? (4)
Can “new” mutant alleles in human genes that encode misfolded ion channels be rapidly identified and
characterized? This last question reflects the first step toward developing personalized therapies for loss-of-
function ERAD-associated diseases. To answer these questions, the lab will capitalize on emerging techniques
in diverse model systems, each with unique strengths, as well as ongoing collaborations. Innovative tools,
which are new to the field, will also be used. Together, the proposed research objectives lie at the heart of the
lab’s long-term research goals, will address critical knowledge gaps, employ experimentally rigorous and
transdisciplinary strategies, provide the research community with novel methods to address other unanswered
questions in cell biology, and lead to the generation of new testable hypotheses.

Public health relevance
Membrane proteins face substantial hurdles as they fold and assemble in the endoplasmic reticulum (ER), but a dedicated quality control pathway known as ER associated degradation (ERAD) selects and destroys misfolded membrane proteins. Yet, how misfolded integral membrane ERAD substrates are prevented from trafficking beyond the ER in human cells, and how toxic aggregation-prone membrane proteins are destroyed are poorly understood. These knowledge gaps will be addressed by applying innovative tools, developing new models, and working with resident experts. In addition, most ERAD substrates were discovered in a nonsystematic manner; therefore, another objective is to apply a new computational-experimental pipeline to uncover previously uncharacterized amino acid variants that destabilize two ion channels, thus leading to the identification of “new” disease-associated ERAD substrates.